Developing closed-loop tonic motor activation therapy for treatment of refractory restless legs syndrome

Summary: Restless Legs Syndrome (RLS) is a prevalent and debilitating sleep disorder that affects a significant
portion of the adult population, leading to considerable sleep deprivation and a reduction in quality of life. Current
treatments for RLS provide mixed results and, in the case of medications, undesirable side effects. The need for
innovative solutions is clear. The Noctrix Tonic Motor Activation system (TOMAC) represents a novel approach
to RLS management through non-invasive peripheral nerve stimulation, offering a promising alternative to tradi-
tional therapies. Despite the success of TOMAC 1.0 in reducing RLS symptoms, challenges remain in reducing
sleep fragmentation and facilitating medication reduction. The proposed SBIR Phase IIB project aims to develop
and clinically validate a closed-loop version of TOMAC (CL-TOMAC) to address these unmet needs. CL-TOMAC
will use leg movement detection algorithms developed in the prior SBIR Phase II to automatically activate therapy
during sleep to reduce wake after sleep onset (WASO). Additionally, CL-TOMAC will facilitate reduction in the
dosage of common RLS medications (dopaminergics and opioids), alleviating the side effects associated with
long-term medication use. The project is structured around three Specific Aims: 1) Develop and verify a closed-
loop stimulation algorithm that is sensitive and specific in detecting the need for activation during sleep, 2) Assess
the feasibility of CL-TOMAC in reducing WASO in patients with refractory RLS, and 3) Evaluate the potential of
CL-TOMAC to facilitate reductions in common RLS medication dosages. Success will be measured through
rigorous clinical and technical validation processes, including polysomnography, actigraphy, and medication dos-
age assessments. By addressing these critical challenges, CL-TOMAC promises to improve health outcomes
and enhance quality of life for those affected by RLS. Following successful completion, the results of Aims 2-3
will determine the intended use for CL-TOMAC (expanded to include medication reduction and/or reduced
WASO), guide the design of a pivotal trial for FDA clearance, and inform the choice of patient populations to
target in the commercialization strategy.

Public health relevance
Narrative: Restless Legs Syndrome, characterized by uncomfortable and often severe leg discomfort especially at night, affects more than one in ten adults in the United States, contributing to the widespread prevalence of sleep disorders in what the Centers for Disease Control have declared a public health epidemic. Drug and de- vice-based RLS therapies have met with mixed results, with no new therapies approved by the FDA in more than 10 years until our successful commercial introduction of Tonic Motor Activation (TOMAC 1.0) using non-invasive peripheral nerve stimulation in 2023. In this proposal, we develop and validate a closed-loop Tonic Motor Acti- vation system (CL-TOMAC) for automated therapy delivery based on novel leg movement algorithms to sub- stantially reduce sleep fragmentation and enable greater reduction in medication (e.g., opioids and dopaminer- gics) dosage to promote increased quality of life.